Preventing Loss of Independence through Exercise in Community Living Centers: An Effectiveness-Implementation Trial

Background: Preventing Loss of Independence through Exercise (PLIÉ) is a unique, mind-body, group
movement program for people living with cognitive impairment and dementia that has been found to have
physical, cognitive, social, and emotional benefits. We received a VA Innovators Award to implement PLIÉ in
the San Francisco VA Community Living Center (CLC), where it became one of their most successful and
popular programs. As part of our ongoing VA HSR&D pre-implementation grant (1I01 HX002764), we have
developed and piloted a remote PLIÉ staff training program and have successfully trained 50 interprofessional
staff members at 5 CLCs. This study will enable us to test the effectiveness and implementation of PLIÉ-CLC.
Significance: VA CLCs serve approximately 40,000 Veterans annually, most of whom have one or more
severe neurocognitive, mental health or physical impairments; yet CLC staff members typically do not receive
specialized training in how to best engage and interact with these Veterans. This training and knowledge gap
can result in poor care quality, declines in physical function, increased distressed behaviors, staff burnout, and
low morale throughout a facility.
Innovation & Impact: PLIÉ-CLC provides an efficient format for delivering high-quality care to groups of
residents with cognitive impairment. Veterans with complex care needs often receive care from different
providers who do not necessarily communicate with each other about the residents’ needs. PLIÉ-CLC provides
a structured framework for interprofessional staff members to work together to simultaneously address
residents’ physical, social and mental health needs. In addition, PLIÉ-CLC provides an efficient experiential
training model. Staff members, trainees and family members are invited to join classes where they can learn by
doing and can directly observe the beneficial impact of the classes on residents.
Specific Aims: The goals of this study are to: 1) Determine the effectiveness of PLIÉ-CLC on resident-
centered outcomes (primary outcome: physical function; secondary outcomes: social engagement, mood,
cognitive function, behaviors, falls, and pain); 2) Determine the effectiveness of PLIÉ-CLC on person-centered
care practices and organizational culture, including staff engagement, burnout, and workplace climate; 3)
Evaluate implementation of PLIÉ-CLC, including reach, adoption, external facilitation, and fidelity; 4) Examine
the extent to which PLIÉ-CLC is sustained after external facilitation support has ended.
Methodology: We proposed to achieve these Specific Aims by performing a Type 2 Hybrid Effectiveness-
Implementation study using a stepped wedge cluster randomized trial design. This design will enable us to
assess the effectiveness of PLIÉ-CLC at the resident (Aim 1) and organizational (Aim 2) levels and the
implementation process itself at the clinician and organizational levels (Aims 3, 4). We will use a concurrent
mixed methods approach to qualitative and quantitative data collection and analysis guided by the Practical,
Robust Implementation and Sustainability Model (PRISM).
Next Steps/Implementation: We will work with our partners in the VA Office of Geriatrics and Extended Care,
Office of Patient Centered Care & Cultural Transformation, and Mental Health & Suicide Prevention to use the
findings from this effectiveness-implementation trial to inform decisions about sustainable roll out and
implementation of PLIÉ-CLC nationwide.

Public health relevance
Approximately 40,000 older Veterans who have complex care needs (for example, a combination of severe cognitive, physical, and mental health conditions) receive long-term care in VA Community Living Centers (CLCs). However, CLC staff members rarely receive specialized training in how to best engage and interact with these Veterans, which can lead to poor care quality, worsening of symptoms, staff burnout, and low morale throughout a facility. We have developed a unique, mind-body, group movement program for Veterans with cognitive impairment called Preventing Loss of Independence through Exercise (PLIÉ) and found that it has physical, cognitive, social and emotional benefits in CLC residents. We recently taught 50 staff members from a variety of professions in 5 CLCs to lead PLIÉ classes. The study will enable us to test whether the PLIÉ- CLC staff training program improves outcomes for residents and to learn about the success and sustainment of the training.